Core B - Instrumentation/Microscopy/Histopathology

CORE B – PROJECT SUMMARY/ABSTRACT
The Instrumentation / Microscopy / Histopathology Core provides support for facilities and equipment used
communally by members of the PPG. Aim 1 is to provide priority access to and instruction in the use of critical
instrumentation including 1) high-speed ultracentrifuges; 2) a Typhoon 8610 Imager; 3) an ABI Prism 7900HT
real-time PCR machine; and 4) a Beckman Spectrophotometer DU7400. Aim 2 is to provide priority access
to and instruction in the use of advanced PPG microscopy resources including a Zeiss Axioimager suite, a
Zeiss Axiovert 200M 3-D deconvolution live cell imaging microscope, two Nikon Ti-Eclipse live cell imaging
deconvolution microscopes, and a fully automated Nikon A1R confocal microscope. Aim 3 is to provide PPG
members with essential shared histopathology services for generating, processing, and visualizing formalin-
fixed, paraffin-embedded and frozen tissue samples for tumor virus-associated cancer studies. Combined,
this Core (formerly the “Instrumentation” Core) has been extensively used over the current funding period,
and is now expanded in its capacity to include additional microscopy and histopathology capabilities needed
across the five projects of this P01.

Public health relevance
CORE B – PROJECT NARRATIVE The Instrumentation / Microscopy / Histopathology Core (Core B) provides shared instrumentation and resources relevant to the success of all projects in this research program that aims to understand how cancer- associated viruses replicate and cause human disease. The core also organizes in-house and external maintenance for equipment, microscopy, and histopathology services, and provides relevant training and support.